Using integrated omics to identify dysfunctional genetic mechanisms influencing schizophrenia and sleep disturbances

The proposed work aims to decipher genetic factors dysregulated in the brains of individuals with
schizophrenia with pleiotropic effects influencing sleep issues. The goals are to inform genomic driven
medical care for improved treatment of sleep problems, which are among the most common co-occurring
conditions in these patients. Sleep disruptions are associated with more severe schizophrenia-related
symptoms. Healthy sleep is important for neurodevelopment, indicating that managing sleep disturbances
may have significant impacts on reducing severity of schizophrenia symptoms and improving long-term
outcomes. Characterizing pleiotropic genetic effects using multiomics data holds promise for informing
precision medicine approaches to treatment of sleep problems in these individuals. Investigators at the
University of Kansas Medical Center have whole brain specimens from human donors diagnosed with
schizophrenia and confirmed controls. This brain bank reflects a diverse collection of specimens from
males and females with different reported race. This project will generate multi-omics data from
sleep-wake regulating brain regions in these specimens and identify genetic variation impacting function
of pleiotropic genes and proteins evidenced to increase risk for both schizophrenia and insomnia-related
symptoms. Variants with evidence for pharmacogenetic and regulatory effects on genes encoding drug
targets will be evaluated. Genetic risk scores calculated from sequence data that are useful to predicting
risk and aiding in early detection and intervention will be functionally validated. In addition, this project will
comprehensively characterize gene and protein coexpression connecting two important brain regions
known to regulate human sleep behaviors. Combining evidence from the genome, transcriptome and
proteome will allow for discerning the biochemical pathways and genetic mechanisms dysregulated in
sleep-wake regulating brain regions from these patients and help identify proteins that can be targeted by
small molecule compounds to treat sleep problems more effectively. This work should also provide
knowledge of how convergent mechanisms influence risk for multiple disorders in the same individual.
The approaches developed and data generated in this project will provide a rich resource that will be
shared with the larger scientific community allowing for investigations of the sleep regulation network in a
diverse representation of individuals with mental health conditions.